Cancer Center Administration

PROJECT SUMMARY – ADMINISTRATIVE CORE
Successful cancer centers, whether freestanding or matrix, master complexity, navigate dynamic external
environments, and deliver cancer discovery to their community and patients. Effective administration provides
infrastructure of quality services and partners with leadership and stakeholders to prospectively design a
strategic future orientation in the form of a plan. UWCCC Administration oversees 37 FTEs with key activities
including: lead, draft, and execute UWCCC’s strategic plan; develop and manage multiple and complex
sponsored research awards (pre and post); provide fiscal oversight; govern information systems and informatics;
direct marketing efforts; direct multidisciplinary translational research administration; coordinate training and
public/professional education initiatives; administer community outreach and engagement efforts; coordinate
development efforts; manage facilities; provide human resources; embrace differences and promote fairness
and equity while fostering a sense of belonging; and continuously improve the organizational structure necessary
to accomplish the center’s educational and research missions. UWCCC encompasses 218 core members, >290
staff FTEs, a $31M annual overall budget, and a $5.3M annual administrative budget.
UWCCC’s administrative infrastructure successfully achieved many high impact accomplishments during the
award period, including: 1) the creation of a center-wide strategic plan and (85%) completion of a prior plan; 2)
successful centralization of COE operations; 3) the formation of inaugural educational coordination infrastructure;
4) the creation of key inaugural steering committees to govern CTMS informatics, campus-wide shared resource
management and Oncology education; 5) the creation of the inaugural clinical research internship; 2019
formation of diversity and equity staff committee; 6) successful intermural funding application and state funding
request for precision medicine omics database ($450K/annual); 7) expansion of complex grant submissions
including two SPOREs, successful NCTN and CISNET awards, and an increase of >10 P/U mechanism
submissions from prior grant period; 8) expansion of clinical trials navigation office; 9) restructure of clinical trials
office to include a multi-site office and new key disease team roles in education and protocol activation, meeting
both mission needs and retaining key staff with career paths (turnover never exceeding 25%); 10) launch an
inaugural campus-wide shared resource marketing fair; 11) expand the trial budget negotiation capacity by
supporting a 42% increase in new contracts, while decreasing the average budget negotiation by 63 days; 12)
propose a successful award in informatics (CCSG 46S3) to develop solutions to the time-consuming, and
repetitive EHR builds of clinical trial treatment plans; 13) and closeout (>5–20 years of age) trial accounts to
reinvest $1.5M into clinical research expansion.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.